2025 Tissue Engineering and Regenerative Medicine International Society – Americas Chapter (TERMIS-AM) Annual Meeting

The University of Michigan and the Tissue Engineering and Regenerative Medicine International Society, Americas Chapter (TERMIS-AM) will be hosting and organizing the upcoming 2025 meeting of the TERMIS, Americas Chapter (TERMIS-AM) Conference and Exposition. Michigan is requesting support for travel awards for the Student and Young Investigator Section (SYIS) trainees to attend the full conference. The theme of the conference and the highlight of the meeting is “Next Generation Tools for Regenerative Medicine.” The preconference symposia will focus on strategies for accomplishing translational research and bringing regenerative medicine therapies to the clinic.

Public health relevance
The field of regenerative medicine has the potential to improve human health by providing new approaches and technologies to restore damaged and diseased tissues. The theme of the TERMIS 2025 meeting will be “Next Generation Tools for Regenerative Medicine,” and will focus on disseminating novel information on regenerative medicine technologies that will revolutionize the treatment of disease and injuries. The location of the meeting will be Detroit, Michigan, a city with a history of innovation and industry in the United States and its surrounding universities have become a hub for developing regenerative medicine technologies.